Medical University of South Carolina NCORP Minority/Underserved Community Site

PROJECT SUMMARY
The Medical University of South Carolina/Hollings Cancer Center (MUSC/HCC) was established
as a Minority Underserved site in 2014 to expand and enhance the NCORP trial portfolio by
accruing racially/ethnically diverse patients and those from other medically underserved groups
into NCORP studies, share expertise and experience on minority recruitment and retention and
cultural diversity within the NCORP community, and contribute to the development and
implementation of cancer care and cancer delivery research. During the current project period,
the MUSC NCORP-MU, which is comprised of two MUSC/HCC sub-affiliates and five community
oncology primary affiliates, has made significant contributions to the NCORP program through
the effective and efficient accrual of diverse patient populations and leadership that has shaped
the scientific agenda for clinical trials, cancer health disparities, and cancer care delivery
research. These accomplishments were made possible through a highly invested and
transdisciplinary investigative team consisting of Chanita Hughes-Halbert, PhD (Psychiatry &
Behavioral Sciences), Marvella E. Ford, PhD (Public Health Sciences), Carolyn D. Britten, MD
(Medical Oncology), and David T. Marshall, MD (Radiation Oncology) that has worked hand-in-
hand with the clinical research operational leaders at the MUSC/HCC to establish and manage a
robust clinical research operation to add value to NCORP. This leadership team has also worked
collaboratively with other committed clinical and cancer control researchers, oncology care
providers, cancer patients, and survivors in our catchment areas to advance all types of cancer
research through the NCORP research bases. The MUSC NCORP-MU aims to improve equity
and access to clinical research among racial/ethnic minorities and other medically underserved
groups in order to improve cancer outcomes, enhance the quality of cancer care delivery, and
reduce cancer health disparities within South Carolina and communities across the US.

Public health relevance
PROJECT NARRATIVE Continuation of the Medical University of South Carolina NCORP Minority/Underserved Community Site will provide greater emphasis and availability for residents and healthcare providers of South Carolina to participate in cancer prevention and control, screening, post treatment surveillance, cancer care delivery, treatment, and imaging research studies.